The Role of Adenine Nucleotide Translocase in Mitochondrial Dysfunction Associated Senescence in Chronic Obstructive Pulmonary Disease (COPD)

PROJECT SUMMARY
Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death in the United States with
no current therapies that significantly alter disease progression. Cigarette smoke (CS) is a major causative factor
in COPD that results in mitochondrial dysfunction and reactive oxygen species (ROS). Alveolar epithelial type 2
cells (AEC2s) are essential progenitor cells for normal lung homeostasis (cell renewal) and epithelial repair after
CS injury and in COPD. Mitochondrial dysfunction and cell senescence, a state of cell cycle arrest, have been
implicated in COPD and may reduce AEC2 cell progenitor function and epithelial repair. The causative
mechanisms and functional consequences of mitochondrial dysfunction on AEC2 senescence and
epithelial repair in COPD remain major knowledge gaps and may provide new insights for the
development of therapeutic approaches. The major goal of this proposal is to determine how mitochondrial
dysfunction mediated by adenine nucleotide translocase 2 (ANT2) contributes to cellular senescence and
abnormal epithelial cell repair in chronic obstructive pulmonary disease (COPD). Adenine nucleotide translocase
2 (ANT2) is a mitochondrial ATP transporter critical for cell metabolism and fate. We have shown that ANT2
gene expression is reduced in lung tissue from patients with COPD and that ANT2 knockdown in human
bronchial epithelial cells results in reduced mitochondrial respiration (Kliment et al, J Cell Sci 2021). Our
preliminary data show that human ANT2 is specifically reduced in AEC2s from COPD lungs. Knockdown of
ANT2 in epithelial cells in vitro results in increased p21 and p16 (markers of senescence). In a mouse CS model
of COPD, loss of ANT2 in alveolar epithelial cells results in enhanced lung destruction (emphysema), increased
p21 and p16 in AEC2s, and increased ROS. This proposal will determine how ANT2 protects against
emphysema by modulating ROS production, mitochondrial metabolism and senescence in AEC2 cells
and epithelial repair after CS. Our study will determine the following: 1) To test the hypothesis that loss of
ANT2 in AEC2 cells drives senescence by increasing ROS and the DNA damage response (DDR). 2) To test
the hypothesis that loss of ANT2 shifts AEC2 metabolism and decreases repair capacity to promote COPD. 3)
To test the hypothesis that therapeutic restoration of ANT2 or removal of senescent cells can protect against
emphysema. The outcome of this proposal will define the mechanisms by which mitochondrial dysfunction and
shifts towards glycolytic metabolism due to loss of ANT2 drives senescence and dysregulated epithelial repair
in AEC2 cells in COPD. Elucidation of ANT2 as a major regulator of lung epithelial repair and senescence through
mitochondrial dysfunction provides critical knowledge connecting these processes and will inform the discovery
of new COPD therapies.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a prevalent and progressive obstructive lung disease caused by cigarette smoke exposure with few effective therapies. The role of mitochondrial dysfunction and cellular senescence, a state of cell arrest, in COPD pathogenesis remain unknown and an area of high scientific interest. This work will define how adenine nucleotide translocase (ANT2), a mitochondrial ADP/ATP translocase, influences mitochondrial dysfunction that drives cellular senescence and abnormal repair of the lung epithelium, thus opening the potential for ANT as a therapeutic target for COPD.